Novel Tracheostoma Device

ABSTRACT
Surgical removal of the larynx profoundly affects a patient’s quality of life, particularly in the loss of normal
vocalization, physical change in appearance, and emotional challenges to adapt to living a normal life. Post
operatively, a laryngectomy requires a patient’s stoma to be protected utilizing various heat moister exchange
(HME) filters, which attach with devices either (i) extraluminal using adhesives and straps around the stoma or
(ii) intraluminal using a tracheostomal button (“TE Button”) inserted into the stoma. Utilization of either device is
challenging for the patient, extraluminal adhesive-based devices require change several times per week, causing
tissue irritation and injury, social and emotional stress, frustration, and device failure. The existing products for
laryngectomy patients have been void of meaningful innovation for over 20 years, utilizing antiquated materials
while ignoring the vast number of innovations in biocompatible materials and technology that could address most
patient issues. TE Button failure is easily identifiable and the byproduct of TE Buttons’ circular and rigid design
which unevenly displaces pressure due to lack of uniformity unique to each laryngectomy regarding
tracheostomal anatomy. This results in poor tolerability and retention due to dermal irritation, tissue erosion, and
random dislodging from the stoma caused by the device’s movement within the tracheal lumen during normal
daily activities, speech, and respiration. Most laryngectomy patients have undergone months or years of
traumatic surgeries, chemotherapy, and radiation then attempt to reenter society with significant changes in
physical appearance, social anxieties, emotional stress, and frustration as they adapt to their ‘new’ normal quality
of life. TE Button failures limit a patient’s ability to successfully utilize various intraluminal attachments such as
a Tracheoesophageal (TE) voice restoration devices for hands-free TE speech production. These TE Button
failures reduce quality of life, impeding the ability to return to normal daily routines and activities after total
removal of their larynx. This Phase I proposal aims to develop a TE Button capable of improved stability,
durability, reduced pistoning and relative motion because it adapts to various stomal geometries and
configurations. This project will provide an alternative for hands-free speech production to patients who are
unable to use currently available intraluminal devices. We aim to utilize the advances in material sciences that
have occurred since the original tracheostoma buttons were invented. These include high elongation, high tear
strength, low durometer silicone elastomers and the lower cost of Nitinol wire and composites of wire such as
braids and stents.

Public health relevance
NARRATIVE The Tracheoesophageal (TE) Button market has lacked significant innovation and continues to utilize the same materials for the past 20 years. The goal of this Phase I proposal is to introduce significant innovations from better biocompatible materials and unique designs that can address most of the TE Button issues, including the discomfort and tissue irritation induced by the device.